YAP1 and RB1 cooperate to regulate lung cancer lineage plasticity and therapeutic resistance

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-045. Patients with EGFR mutant lung adenocarcinoma (LUAD) are treated with EGFR tyrosine kinase
inhibitors (TKI) because they yield better patient outcomes than previous standards of care. EGFR TKI are not
curative, however, as virtually all patients progress on therapy due to acquired drug resistance. While genetic
mechanisms of acquired EGFR TKI resistance are well understood, non-genetic mechanisms also play an
important role. Dynamic and reversible transcriptional adaptations involving lineage state changes support the
survival and progression of LUAD cells during treatment. The mechanisms and genetic determinants controlling
this LUAD lineage plasticity are not well understood. Advancing fundamental understanding of LUAD lineage
plasticity is a prerequisite for the development of therapeutic approaches to predict it, suppress it, and improve
therapeutic outcomes. Through analysis of both clinical specimens and experimental models, the collaborating
investigators have discovered that minimal residual disease surviving EGFR TKI shows induction of a quiescent,
alveolar lineage state. This state is lost in cells proliferating and progressing through EGFR TKI and is replaced
by alternative lineage states less dependent on oncogenic EGFR signaling. In currently parallel lines of research
within the collaborating investigators labs, YAP1 activity has been demonstrated to drive the alveolar lineage
state while RB1 loss accelerates the further transition to alternative, EGFR independent lineage states. These
findings suggest YAP1 and RB1 interact to control lineage state transitions during EGFR TKI therapy that
ultimately facilitate acquired therapeutic resistance. This ARTNET supplement application is proposed to
support collaborative research in two specific aims that will test this hypothesis and validate new genetically
engineered mouse models for studying LUAD lineage plasticity in vivo, additionally enabling the study of how
non-malignant cells within the tumor microenvironment influence LUAD lineage plasticity and vice versa.

Public health relevance
Project Narrative EGFR tyrosine kinase inhibitors (EGFR TKI) are standard of care for patients with advanced EGFR mutant lung cancer, but they are not curative because of acquired therapeutic resistance. This application will identify molecular determinants of lung cancer lineage plasticity that contribute to acquired EGFR TKI resistance.